Local and global consequences of hyperphosphorylated tau in the locus coeruleus in Alzheimer's Disease

PROJECT SUMMARY
Alzheimer’s disease (AD) is the most common form of dementia world-wide, afflicting nearly 46 million
people. The two hallmark AD pathologies are extracellular β-amyloid (Aβ) plaques and intracellular aggregated
tau, termed neurofibrillary tangles. Many treatments that target amyloid deposition in mid to late stages of disease
are effective in animal models but have failed in clinical trials. However, recent evidence indicates that
hyperphosphorylated “pre-tangle” tau in the noradrenergic locus coeruleus (LC) appears decades prior to
cognitive symptoms and Aβ deposition, offering fresh insight into the potential cause and progression of AD. The
LC coordinates distinct brain states through norepinephrine release at target sites, and many LC-modulated
behaviors go awry in AD, but few studies have directly investigated the consequences of aberrant tau on LC
function. Aberrant tau expression causes hypoactivity in neurons, and tau load is associated with blunted novelty
response, a key behavior influenced by LC activity. Furthermore, the LC does not exhibit frank neuronal loss
until late stages of disease when cognitive decline is evident, but neuron morphology is altered, and innervation
density is decreased at early stages of disease. Despite these potentially pathogenic changes, our data indicates
that activation of the LC has the potential to restore normal cognition. In TgF344-AD transgenic rats, similar to
humans, hyperphosphorylated tau appears in the LC prior to tau or Aβ pathology in the forebrain. Importantly,
chemogenetic activation of the LC is effective at rescuing spatial learning deficits in aged TgF344-AD rats,
indicating that LC stimulation enhances cognition even in the presence of AD-like neuropathology in the LC and
forebrain. However, there is no information regarding the effects of tau on LC physiology or LC-induced changes
in brain-wide functional connectivity.
In this proposed project, I will use TgF344-AD rats to assess both tau-mediated LC neuron dysfunction
and the therapeutic potential of LC stimulation to correct functional connectome deterioration. In Aim 1, I will use
in vivo electrophysiology to determine whether hyperphosphorylated tau in the LC can alter neuron firing rates
in an age-dependent manner. In Aim 2, I will combine optogenetic stimulation of the LC with simultaneous
functional magnetic resonance imaging to assess whether LC stimulation can rescue brain-wide network
functional connectivity deficits. I hypothesize that aberrant tau will decrease neuron firing rates in an age-
dependent manner that will be paralleled by gradual, brain-wide hypoconnectivity, which will be corrected by
optogenetic LC stimulation. Completion of these aims will determine the functional consequences of the earliest
known AD pathology, hyperphosphorylated tau in the LC, and facilitate development of LC-NE based therapeutic
interventions to retard progression.

Public health relevance
PROJECT NARRATIVE Alzheimer’s disease (AD) is the leading form of dementia world-wide and one of the leading causes of death in the United States, with patients suffer from debilitating cognitive decline, while families, caregivers, and society bear immense economic and emotional burden. Rates of AD will rise as the population ages, making it a prevailing health problem for the foreseeable future, but no disease-modifying therapies currently exist. This proposal will test the hypothesis that AD pathology in the locus coeruleus-norepinephrine system disrupts neuronal firing rates and can be targeted by stimulation to restore communication in cortical networks, which can pave the way for development of novel therapeutics.